PCB Emissions from Contaminated Water and Soil

SUMMARY: Project 4 – PCB Emissions from Contaminated Water and Soil
Exposure to airborne polychlorinated biphenyls (PCBs) poses a significant risk of human exposure to these
harmful compounds, raising concerns among communities living near PCB-contaminated sites nationwide.
Airborne PCBs originating from PCB-contaminated waterways and soils are a pressing issue, exacerbated by
sediment dredging, a common remediation method. However, the impact of dredging on PCB emissions
remains unclear. With numerous PCB Superfund sites—over 50 designated and many unregistered—the
extent of airborne PCB emissions' variability remains unknown. This knowledge gap is due to inadequate
sampling tools and infrequent air monitoring at these sites, as well as limited data on environmental
compartment exchange rates. Project 4's overall goal is to comprehend PCB behavior in complex
environmental systems, identify sources and emissions, and reduce exposure to nearby populations. The
project aims to characterize novel passive samplers tailored to assess emissions from airborne PCB sources:
sediment dredging operations and contaminated soils. Our central hypothesis is that PCB emissions from
these two sources are a function of the physical-chemical properties of PCBs and concentrations of PCBs in
sediment, soil, water, and air that can be characterized using appropriate sampling tools, and that these
emissions are determined by exchange rates between environmental compartments and the prevailing
environmental and hydrological conditions. Project 4 collaborates with the ISRP, aligning with other projects to
identify and reduce PCB exposure. Partnerships with stakeholders, including the Great Lakes National
Program (GLNPO) EPA, Portland Harbor Community Coalition, and Oregon DEQ, ensure relevance. In Aim 1
we will focus on exploring PCB exchange among sediment, soil, water, and air within a laboratory mesocosm.
This will enhance our understanding of how environmental parameters impact the behavior of PCB in the
environment and facilitate the development of new passive sampler techniques. In Aim 2, we will study the
effect of dredging operations and the distribution of PCB-contaminated soils on emissions through Superfund-
relevant case studies. Subaim 2.1 we will investigate emissions during dredging operations, collaborating with
GLNPO EPA to capture diverse emission patterns. Subaim 2.2 we will assess temporal and spatial emissions
from PCB-contaminated soils at Portland Harbor Superfund site, utilizing innovative soil emission samplers.
Upon completing these aims, the project anticipates the development of novel sampling tools for airborne PCB
emissions, enhancing understanding of contributions from sediment dredging and soil sources. This insight will
benefit partner communities, including Portland Harbor, as well as other PCB Superfund sites and
stakeholders like EPA, DEQs, and Superfund managers.

Public health relevance
NARRATIVE: Project 4 – PCB Emissions from Contaminated Water and Soil Project 4 focuses on investigating airborne PCB emissions from contaminated water and soil sources, particularly sediment dredging and PCB-contaminated soils. The project aims to develop specialized passive sampling methods, enhance understanding of PCB exchange in laboratory mesocosms, and assess emissions from specific case studies. The findings will aid in predicting and managing PCB emissions, benefiting communities near Superfund sites and relevant stakeholders.